Unraveling the cell networks in bone marrow through transcriptomic and epigenetic profiling

Project Summary
Bone marrow is a highly complex and heterogeneous environment, composed of hematopoietic,
mesenchymal, nervous and endothelial tissues. It is the site of a wide range of diseases including blood and
immune disease (leukemia, myelodysplastic syndromes, aplastic anemia, myelofibrosis), skeletal disease
(osteoporosis, osteopetrosis, Paget’s disease), vascular disease (avascular necrosis, ischemic and
hypertension-related bone disease), and cancer metastasis (breast, prostate, thyroid). There is a great
appreciation for the role of mesenchymal cells in orchestrating bone remodeling, angiogenesis and
hematopoiesis – functions that are critical to maintaining health and that deteriorate with aging – but there is
little knowledge on how this population is maintained or how it helps regulate the cellular diversity in bone
marrow. Transcriptomic data has started to shed light on bone marrow cell regulation, but since bone marrow
is primarily composed of hematopoietic cells, current data, particularly from humans, lack a holistic
representation of all bone marrow cell types. Additionally, there is a lack of human data regarding how
mesenchymal stem and progenitor cells are maintained, how they repopulate the bone marrow stroma and
which mesenchymal cells are critical to each stage of hematopoiesis. This project seeks to achieve two
interconnected goals: generate a complete single-cell transcriptomic and regulomic map of human bone
marrow cells and experimentally establish the mesenchymal hierarchy in human bone. In order to accomplish
this, we developed a protocol to isolate single-cell suspensions from human femoral head tissue, enrich for
rare or difficult to isolate cell populations (i.e. mesenchymal cells, adipocytes, hematopoietic stem and
progenitor cells) and isolate single-nuclei for simultaneous transcriptomic and epigenomic sequencing. This
information will provide insight into how cell fates are regulated and what cell-cell interactions support cell fate
decisions. Of particular interest is what epigenomic changes determine mesenchymal cell fate and what
epigenomic states of hematopoietic cells make them more amenable cell regulation be one mesenchymal cell
over another based on transcriptomic signatures. Transcriptomic and epigenomic studies will complement in
vivo explant and in vitro differentiation studies to determine mesenchymal lineage differentiation patterns. By
performing flow sorting for four progenitor cells, the studies will define the differentiation potential and position
each cell on the step-wise differentiation pathway to osteogenesis and adipogenesis. This will provide insight
into how mesenchymal cell fate is regulated and what cell types are required for hematopoietic recruitment and
maintenance. By unraveling the complex bone marrow cellular signaling networks, the long-term goal is to
develop novel therapies for osteoporosis and blood disease and provide the research community with a rich
dataset to catalyze further discoveries.

Public health relevance
Project Narrative Bone marrow is a highly diverse tissue containing mesenchymal, endothelial, hematopoietic and lymph cells that together serve a multitude of functions. On a holistic level, it is unclear how these diverse cell types coordinate cell-fate decisions, and, particularly, how mesenchymal lineage cells, a relatively rare bone marrow cell type, are maintained. Developing a comprehensive, human, single-cell transcriptomic and epigenomic bone-marrow atlas, along with experimental validation, will provide insights into cellular regulation and could uncover new therapeutic targets for bone marrow and blood related disease.